Rational design of a safe recombinant Candid#1 vaccine

Arenaviruses are endemic in rodent populations and can be transmitted to humans to cause severe life-
threatening hemorrhagic fevers. Relevant US agencies (DHHS, DHS and DoD) and the WHO recognize these
viruses as high priority pathogens that pose a serious threat to public health and national security. The live-
attenuated Candid#1 strain of Junín virus (JUNV) is currently used in Argentina to protect against Argentine
hemorrhagic fever, but this virus carries the distinct liability that attenuation is solely dependent on a single
phenylalanine-to-isoleucine substitution at position 427 (F427I) in the GP2 fusion subunit of the JUNV
envelope glycoprotein (GPC). Indeed, reversion at the attenuating position occurs readily in cell culture and in
laboratory animals. The current proposal seeks to capitalize on our understanding of GPC structure and
function to design recombinant Candid#1 (rCan) viruses that stably maintain attenuation without compromising
protective efficacy. We have discovered an epistatic interaction between the attenuating F427I mutation in GP2
and a lysine-to-serine mutation at position 33 (K33S) in the stable signal peptide (SSP) subunit of GPC that
provides an evolutionary barrier against reversion to the pathognomonic F427. Pilot studies indicate that K33S
rCan is indeed attenuated in guinea pigs and capable of eliciting protective immunity against lethal challenge
with JUNV. We hypothesize further that safety in a K33S rCan vaccine can be additionally enhanced by
incorporating well-characterized and genetically stable GPC deletions. By characterizing rCan viruses that
embody these strategies, we aim to enhance safety in a second-generation rCan vaccine. Towards this goal,
we will pursue the following specific aims: Aim 1. Determine the degree of attenuation and genetic stability
of K33S rCan in mice. We will utilize well-established mouse models to determine the degree of attenuation in
rCan variants and confirm the genetic stability of the attenuating F427I mutation. Aim 2. Assess the balance
of attenuation, immunogenicity and protective immunity of K33S rCan in the guinea pig model of lethal
JUNV infection. Guinea pigs serve as the gold-standard model for assessing Candid#1 attenuation and
protective efficacy. We will expand upon our pilot findings to optimize the balance between attenuation and
protective efficacy. We will evaluate production of virus-neutralizing antibodies, an accepted surrogate of
protection, and the ability of the vaccine to elicit virus-specific CD8+ T cells. Aim 3. Design and characterize
rCan variants bearing redundant and genetically stable mutations that promote attenuation. We have
identified two deletions in GPC that support rCan infectivity. We will characterize rCan variants bearing these
deletions to integrate additional layers of attenuation. Taken together, our efforts will establish an optimal
balance of attenuation, genetic stability and efficacy in a second-generation rCan vaccine, and elucidate the
molecular basis for attenuation and the immunologic correlates of protection. These strategies may also be
applicable towards the development of an urgently needed live-attenuated Lassa virus vaccine.

Public health relevance
Arenaviruses, such as Junín and Lassa, cause severe life-threatening hemorrhagic fevers and are recognized as Category A priority pathogens and important targets for vaccine development. Despite use of the classically derived live-attenuated Candid#1 strain of Junín virus in Argentina to protect against Argentine hemorrhagic fever, this vaccine has not been licensed in the US in part due to concerns regarding the stability of attenuation, which relies on a single mutation in the virus envelope glycoprotein (GPC). In this proposal, we will capitalize on our understanding of GPC structure and function to design and characterize recombinant Candid#1 (rCan) viruses that enhance the genetic and phenotypic stability of attenuation, with the long-term goal of developing a safe and effective second-generation rCan vaccine.